Direct characterization and correction of circuit level computational deficits underlying compulsivity in humans

PROJECT SUMMARY
Compulsivity, persisting with set ways of thinking and behaving in the face of negative consequences, is a
prominent component of multiple psychiatric disorders. Given the many millions of patients and family members
impacted by harms stemming from compulsive behavior, there is an urgent need to better understand the circuit
basis of this quintessentially transdiagnostic phenomenon. The objective of this K23 application is to equip the
candidate, a psychiatrist with a strong quantitative research background, to carry out intracranial studies of circuit
level computational deficits in human subjects with serious psychiatric illness. A new generation of Food and
Drug Administration (FDA) approved deep brain stimulation (DBS) devices, precisely targeted and chronically
implanted, can both stimulate and record neural activity. Our preliminary data shows that this new technology
can be successfully incorporated into the treatment of patients receiving therapeutic DBS for severe obsessive-
compulsive disorder (OCD), making it possible to directly record from clinically relevant circuitry as patients go
from sick to well. We propose to pair repeat measures of important cognitive processes (inhibitory control,
reversal learning) with serial neural recordings of key cortico-basal ganglia-thalamo-cortical (CBGTC) circuit
nodes. This experimental design will allow us to ascertain how clinical improvement is accompanied by changes
in cognitive processes, and to uncover the relevant circuit activity. In Aim 1, to identify the cognitive changes
caused by therapeutic brain stimulation we will repeatedly administer validated assays of flexibility (a reversal
learning task) and inhibition (a stop signal task). At each time point we will computationally model relevant
cognitive parameters, so that we can track evolution of decision-making dynamics as treatment progresses. In
Aim 2, we will identify neural underpinnings of the cognitive processes changed by therapeutic brain stimulation.
We have implemented an experimental paradigm that allows for millisecond-precision alignment of behavior data
and neural activity. Each time the participants perform a task, local field potentials (LFPs) will be recorded from
key CBGTC circuit nodes, never previously accessible for study in patients with compulsive disorders. With the
unique opportunity to longitudinally record directly from the basal ganglia in these patients, we will be able to
establish if these circuits do indeed subserve clinically relevant decision-making processes. This K23 proposal
is supported by a carefully assembled, collaborative, and diverse mentorship team with the requisite expertise
in psychiatric DBS, disorders of compulsivity, computational modeling of behavior, and human intracranial
recordings. The candidate will emerge from the mentored research experience equipped to lead independent
studies of deep brain circuit function in real world patients.

Public health relevance
PROJECT NARRATIVE Compulsively persisting with fixed ways of behaving even when negative consequences mount is a central component of many psychiatric disorders. For the first time in psychiatry, is it now possible to longitudinally record from neural circuits during a patient’s treatment course, and to do so while administering sophisticated tests of cognition. Directly studying the neural circuits of individuals undergoing treatment for compulsivity may reveal the biological basis for the kind of rigid thinking and behavior present in a wide range of devastating mental disorders.